Novel Targets to Treat Head & Neck Cancer in Veterans

Abstract
Veterans suffer at a disproportional rate from squamous cell carcinoma of the upper aerodigestive tract,
(SCCUADT) due to carcinogen exposure from tobacco and alcohol. Squamous cell carcinoma of the head
(SCCHN), specifically the oral cavity and larynx is also driven by carcinogen exposure and comprises a lethal
subset of these tumors. Despite aggressive treatments, SCCHN is a devastating disease that portends an
overall 5-year survival of only ~50%. This Merit Review recently identified that an understudied ion channel,
TMEM16A plays a key role in promoting SCCHN proliferation, by activating mitogenic signaling pathways. Not
surprisingly, we found that TMEM16A interacts with EGFR family members, HER2 (Erbb2) and HER3 (Erbb3)
and potentiates intracellular signaling. Interestingly, we surreptitiously discovered TMEM16A overexpression in
pre-cancerous (dysplastic) tissues obtained from patients undergoing cancer treatment. This renewal
application seeks to exploit this finding and determine if TMEM16A plays a critical role in cancer development,
in addition to the role it plays in promoting the growth and proliferation of frankly malignant cells.
This proposal therefore seeks to better understand the mechanism(s) by which SCCUADT develops, so that
we may develop effective strategies to treat the pre-malignant condition before the development of invasive
carcinoma. In order to reach this ultimate goal, we begin by proposing experiments that will elucidate the
fundamental biologic process that underlie the formation of pre-malignant lesions, in the context of carcinogen
exposure and define the mechanisms by which these lesions progress into invasive cancer. Aim I tests the
hypothesis that TMEM16A overexpression is an early event that promotes carcinogenesis. We will (A)
determine if TMEM16A is overexpressed in the earliest stages of carcinogenesis and (B) identify the molecular
mechanisms that regulate this overexpression. We will accomplish this using both human tissues and a mouse
model of carcinogen-induced SCCUADT. Firstly, we will determine if TMEM16A is overexpressed in tissues
that have been exposed to carcinogen, even in the absence of histologic changes. We will also determine if the
level of TMEM16A expression in premalignancy characterizes an increased risk of progression to invasive
cancer. Second, we will extend these investigations to dissect the molecular mechanism(s) that regulate
TMEM16A gene expression. Specifically, we will determine if gene amplification plays a role in this disease
process. We also employ cutting-edge promoter occupancy assays to determine which transcription factors
drive TMEM16A expression.
Aim II tests the model that carcinogenesis is initiated by increased levels of oxidative stress (reactive oxygen
species, ROS) which ultimately triggers a run-away cycle leading to increased TMEM16A and uncontrolled
growth. In this Aim, we will (A) determine the signaling pathways that are activated by TMEM16A and (B)
determine if TMEM16A inhibition will serve a therapeutic strategy to treat dysplasia. We postulate that
increased ROS leads to upregulation of NRF2 signaling. NRF2 acts to increase TMEM16A transcription and
ultimately promotes mitogenic signaling. Using a novel knock-out mouse model, we will determine if TMEM16A
is required for carcinogenesis. Finally, we use pharmacologic inhibitors to target TMEM16A, and implicate it as
a novel therapeutic target.
At the end of the proposed funding cycle, we plan to have characterized the role of TMEM16A in the process of
carcinogenesis of the UADT. We posit that this information will shed valuable insights into the biology of this
understudied disease and identify novel targets that may ultimately prevent the development of cancer.

Public health relevance
Despite aggressive therapy, Veterans with squamous cell carcinoma of the upper aerodigestive tract (UADT) including cancer of the head and neck have a dismal prognosis. Although we have identified novel targets to treat this disease, the improvements in outcomes have been relatively modest. We propose to study how these cancers develop from pre-cancerous lesions. If we can prevent or slow the progression to cancer, we may be able to treat these patients before they develop cancer. The calcium-activated chloride channel TMEM16A/ ANO1 is frequently overexpressed in these cancers and contributes to tumor cell growth. TMEM16A appears to promote carcinogenesis by driving cellular signaling. Interestingly, we find that TMEM16A is increased in pre-cancerous lesions. This proposal outlines studies that will elucidate the fundamental biology of TMEM16A and how it promotes carcinogenesis. We will address the unmet need by implicating TMEM16A as a potential therapeutic target for the treatment of Veterans with cancer of the UADT, and head & neck in particular.